Mitochondrial Membrane Dynamics in Th17 Cells

Modified Project Summary/Abstract Section

The failure to engage specific and appropriate metabolic programs can impair or alter T cells, and thus lead to ineffective, or even overexuberant, immune responses. Central to metabolism are mitochondria, which serve as central hubs of energy generation and biosynthetic activity. Work from our group and others has provided mechanistic insights into how mitochondrial metabolism is critical to T cell differentiation and function. However, knowledge about why these organelles change shape to maintain metabolism, biosynthetic capacity, and function, and in what ways mitochondrial remodeling influences T cell activation, differentiation, or effector molecule expression is lacking. Investigating how dynamic changes in mitochondria regulate metabolism to impact CD4+ T cells will enhance our fundamental understanding of immunobiology and of how to manipulate these cells for disease therapy in the context infection, autoimmunity, and inflammatory diseases. In our initial experiments we found that unlike other Th cell subsets, Th17 cells, a cell type necessary for maintaining gut homeostasis and implicated in certain types of autoimmunity and inflammation, had elongated mitochondria in a fused network, as well as tight cristae morphology. These results suggested a differential role for mitochondrial fusion and the protein OPA1, which mediates both membrane fusion and cristae morphology, in these cells. OPA1 deletion had no discernible effect on Th1 and Th2 cell differentiation or cytokine production in vitro, and while Th17 cell differentiation was also unimpaired, IL-17 expression was drastically reduced. Further, mice with a T cell-specific OPA1 deletion were resistant to developing pathology in experimental autoimmune encephalomyelitis (EAE), a Th17 cell-mediated autoimmune disease of the central nervous system. Finally, our data revealed a role for liver kinase B1 (LKB1) in regulating the cellular response to OPA1-deficiency, and in restraining Th17 cell IL-17 expression when mitochondrial fusion is perturbed. In these initial studies we also observed that Tregs had mitochondria that appeared more elongated, making them look more like Th17 cells than other Th subsets. We now propose to investigate the role of mitochondrial dynamics in Treg cells, in addition ot Th17 cells, by using mouse models of colitis and graft-versus-host disease (GVHD). The balance of Treg and Th17 cells is known to be a critical factor in controlling autoimmunity and inflammation. In this proposal we aim to understand how mitochondrial dynamics influence the function of these diverse CD4+ T cell subsets. Our overall goal is to dissect the function of OPA1 in Th17 cell and Treg cell function, and to determine how MM fusion interfaces with LKB1 signaling to modulate cellular metabolism to limit IL-17 expression in settings of mitochondrial disruption or stress in vitro and in vivo, and if and how this may impact Treg suppressive capacity. We propose to 1) explore the role of mitochondrial dynamics in CD4+ T cells, 2) determine the extent to which LKB1 controls the response to OPA1-deficiency in T cells, and 3) investigate how metabolic changes upon disrupting mitochondrial fusion influence Th17 and Treg cell function.

Public health relevance
Modified Public Health Relevance Section Certain types of T cells can promote inflammation and autoimmunity, while others can suppress immune responses. This proposal’s objective is to understand how changes in mitochondria, the so-called powerhouses of the cell, impact the function of different types of T cells. Defining the mechanisms that regulate T cell metabolism will be critical for gaining new insights into how to therapeutically target these cells in the context of autoimmunity, infection, and inflammatory diseases.